Screening for drugs that mobilize ATG9A from the Golgi as a potential therapy for SPG type 47, 50, 51 and 52 diseases

This project aims to identify small molecules that mobilize ATG9A from the Golgi complex in AP-4-deficient cells as a potential therapy for AP-4-deficiency syndrome. In addition, mobilization of ATG9A from the Golgi complex is hypothesized to enhance autophagy in cells that are not deficient in ATG9A, a property that could be explored for the treatment of neurodegenerative disorders caused by accumulation of autophagy substrates, such as protein aggregates in Parkinson's disease, Alzheimer's disease, amyotrophic lateral sclerosis and others.

During this period, the collaborative team has completed primary screening efforts and identified compounds capable of mobilizing ATG9A. Clustering analysis-based MoA was conducted to identify highly enriched targets/pathways, and representative hits are currently undergoing further characterization in orthogonal assays.